Stiffness-mediated genetic selection of cells

Abstract
Studying a cell’s ability to sense and respond to mechanical cues has emerged as a field unto itself over the last
several decades and is now appreciated by engineers and biologists alike. For most cell types investigated thus
far, when cultured on soft substrates they have slower growth rates, smaller spread areas, lower traction, and
lower migration rates than when cultured on stiff substrates. However, there is a critical gap in the literature.
These prior studies, with two notable exceptions, have all taken cell lines previously propagated on plastic
surfaces and assayed cell response to substrate stiffness over the course of a few days to a week. These studies,
which have been seminal and established the field of cell mechanosensing, are limited to short term phenotypic
responses. Taking an intellectual leap, this proposal will test a novel concept of cellular evolution driven by
substrate stiffness. We hypothesize that the mechanical properties of the substrate will select for variants fit
for growth on soft or stiff substrates out of a genetically heterogeneous population of cells, just as drug treatments
select for genetically resistant cells. We will test this hypothesis by performing sustained culture of cells on soft
and hard hydrogels. Across two aims we will quantify how cell phenotypes (growth, motility, metastasis) evolve
as cells are cultured for increasing lengths of time on soft and stiff hydrogels, sequence genomic changes during
this mechano-evolution, and alter the link between mechano-evolution and phenotypic consequences through
targeting mechanosensors.

Public health relevance
Narrative We propose to study how the stiffness of the cell culture environment can drive genetic selection of cells. Previous studies have shown that gene expression changes are transient, whereas we have discovered that cells grown on soft materials maintain growth and motility phenotypes long after they have been removed from those environments. This concept of mechano-selection of genetic variants is novel and will have applications to many aspects of human health.